GROWTH HORMONE SECRETION IN INFANTS AND CHILDREN WITH ALTERED GROWTH RATES

The pattern of pulsatile growth hormone secretion correlated with linear growth in animals. In order to provide insight into the role of endogenous growth hormone secretion in the regulation of altered growth velocity in both normal and pathophysiologic states, growth hormone levels will be determined at 20 minute intervals for 12 hours overnite. The effect of intrauterine events will be studied by comparing infants with intrauterine growth retardation with normal or reduced postnatal growth.